Core A: Program Enrichment/Administrative

CORE A: ADMINISTRATIVE & PROGRAM ENRICHMENT – SUMMARY/ABSTRACT
This Core 1) provides effective leadership, administration and management of the Center; 2) supports an
External Advisory Panel of distinguished scientists who will provide review and recommendations to the
executive leadership of the Center; 3) engages in outreach activities, including workshops, courses, lectures
and symposia; 4) facilitates dissemination of Center resources and research findings to the Gerontological
community; 5) collaborates with other funded Nathan Shock Centers; 6) supports an inter-Nathan Shock
Center Geropathology Research Resource (GRR). The Center Co-PIs, Drs. Rabinovitch and Kaeberlein jointly
direct the Core activities. An Executive Committee assists in making policy decisions and is responsible for
selection of Pilot Proposals. The External Advisory Panel of nationally and internationally respected
gerontologists provides external review and advice.